Impact of Natural Infection on the Baseline Immune States in Humans

Influenza is a year-round public health burden, causing millions of severe illnesses and hundreds of thousands
of respiratory deaths globally. A key challenge in developing more effective vaccines lies in the inherent variability
of the human immune system, as vaccine responses are highly variable across individuals, with many failing to
develop adequate protective immunity. Low vaccine responsiveness has been associated with specific pre-
vaccination baseline immune states. The baseline immune state of an individual determines their immune
function and response. We and others have linked inter-individual variations in vaccination outcomes to
molecular and cellular immune components that encode the baseline state. Our group previously showed that
high vaccine responsiveness is associated with a “naturally adjuvanted” baseline state characterized by
enhanced innate immune response potential, a finding supported by corresponding differences in stimulation
responses of immune cells from high and low vaccine responders in vitro. We also found that clinically healthy
males recovered from mild COVID-19 exhibited a more “poised” baseline state and stronger immune responses
to subsequent influenza vaccination. These studies suggest that variations in baseline immune states contribute
to heterogenous responses to vaccination, and that prior exposures may establish new baseline states that
impact future responses in an antigen-agnostic manner. It remains unclear how infection alters an individual's
baseline state over time, how these changes vary across individuals, and if they have functional consequences.
Using longitudinal samples from a household cohort that allows control for environmental confounders, and using
influenza infection as a model, my proposal aims to address these gaps to better understand the functional
impact of infection on baseline immune states. Given the antigen-nonspecific nature of innate immune cells,
understanding how infection impacts their function is a key to revealing potential underlying mechanisms. I
hypothesize that influenza infection induces durable antigen-agnostic transcriptional and epigenetic changes
that give rise to enhanced innate immune response potential. Aim 1 will assess the impact of infection on
baseline immune states and innate cell response capacity. Through single-cell multimodal immune profiling, I
will assess infection-induced transcriptional and epigenetic changes in peripheral immune cells. Using the same
samples, I will examine innate response capacity to in vitro stimulation. Aim 2 will elucidate how infection-induced
durable changes mechanistically drive innate cell responses to stimulation. I will implement a causal network
inference approach to infer immune determinants of response capacity, followed by experimental validation to
establish causality. This work will advance our understanding of infection-induced antigen-agnostic immune
reprogramming, potentially revealing key drivers of human immune variation and strategies to modulate baseline
states for improving vaccination outcome. Rigorous scientific training will be guided by mentors with experimental
and computational expertise, complemented by longitudinal clinical and professional skill development.

Public health relevance
PROJECT NARRATIVE Influenza remains a major public health burden, and inherent variations in individual immune responses pose critical challenges in developing effective vaccines. Low vaccine responsiveness has been associated with specific pre-vaccination baseline immune states, which can be shaped by prior infections to impact future immune responses. By elucidating how natural influenza infection alters the antigen-agnostic baseline immune states in a household cohort, this project will offer valuable insights into the mechanistic underpinnings of infection-induced immune changes and inform vaccination design and implementation strategies.